Animal and Bioinformatics Core

Project Summary
The Animal Core (Core C) will provide centralized services by generating all the mice
needed for the Center projects. A centralized supply of mice by the Core will ensure that
mice with the same genetic background are used to minimize potential variations in
phenotypic, genomic or epigenomic analyses. The fact that Core personnel are well
trained for HFD treatment, skillful in monitoring development and health status, and
measurement of GTT and ITT will ensure consistent data quality and reproducibility.
Specifically, Core C will generate high fat diet (HFD)- and normal diet (ND)-fed wild-type
and transgenic mice, collect phenotypic data and prepare sperm and tissue samples for
the two basic projects. Both projects 2 and 3 will work on effects of HFD and/or inactivity
on sperm epigenome and offspring health. Both WT or transgenic (TU tracer and
KitcopGFP) mice will be on a HFD or a ND for 3 months, and Project 3 also needs to
reverse the HFD effect by feeding HFD-treated mice with ND and introducing to a
running wheel. To analyze the effects of altered sperm epigenome in response to HFD
and/or exercise, the treated male mice need to be bred with WT female mice to generate
F1 progeny. Core C will maintain the mouse colonies, perform all the treatments, collect
phenotypic data and provide sperm and tissue samples needed for the experiments
proposed in Projects 2 and 3.

Public health relevance
Project Narrative The Animal Core (Core C) will provide all the mice needed by Projects 2 and 3.